SAFETY, TOLERANCE, PHARMACOKINETICS, &BIOAVAILABILITY OF HPMPC IN HIV PATIENTS

This study was designed to assess the safety and tolerance of intravenous, oral, and subcutaneous doses of HPMPC in subjects infected with HIV.